Mechanisms of Change in Behavioral Cough Suppression Treatment for Refractory Chronic Cough

PROJECT SUMMARY
Refractory chronic cough (RCC) is a costly condition that is challenging to treat. While behavioral cough
suppression (BCS) therapy has shown efficacy in clinical trials, it is underutilized and the therapeutic
mechanisms are unknown. Potential targets for BCS therapy include the ascending and descending neural
pathways involved in modulating expression of cough receptors in epithelial tissue, modifying interoception of
urge-to-cough (UTC) sensation, and strengthening inhibitory motor networks. Each of these targets would
ideally reduce cough frequency and cough sensitivity. Capsaicin, a cough stimulant, desensitizes ascending
neural pathways in pain syndromes and chronic rhinitis, showing potential for its use to desensitize cough
pathways. Our pilot research on a version of BCS therapy wherein participants with RCC are trained to
suppress cough in the presence of repeated nebulized capsaicin (i.e., BSC+CAP), has shown promise in
improving cough outcomes. This multi-site randomized clinical trial will evaluate the mechanisms of therapeutic
response to BCS therapy and BCS+CAP for RCC. We will recruit 150 participants with RCC, divided into three
groups—BCS+Sham, BCS+CAP, and capsaicin stimulation alone (CAP). Participants will attend 12 treatment
sessions. Primary outcome measures will be cough sensory threshold (citric acid concentration causing 5 or
more coughs; C5), cough suppression ability (difference between citric acid concentration causing 5 or more
coughs while trying to suppress cough (CS5) and C5), a measure of cough sensory-motor coupling (difference
between first UTC felt and UTC at first dose causing two or more coughs), and cough-related blood oxygen
level dependent (BOLD) neural responses with whole-brain fMRI. Secondary measures will include the
Leicester Cough Questionnaire (LCQ) and ambulatory cough frequency. It is hypothesized that all treatments
will change C5 threshold but only BCS treatments will change UTC sensory-motor threshold difference, cough
suppression ability, and central neural networks, suggesting BCS treatments change cough sensory-motor
processing, while capsaicin stimulation desensitizes peripheral afferent pathways. It is also hypothesized
participants undergoing BCS+CAP will demonstrate the greatest improvement in all measures relative to
BCS+Sham and CAP due to a multi-modal treatment benefit (i.e., desensitization, sensory-motor processing,
cough inhibition).

Public health relevance
PROJECT NARRATIVE Refractory chronic cough (RCC) is a debilitating and frustrating condition that frequently responds to behavioral cough suppression therapy (BCS) therapy. The reason why BCS therapy works could be that it changes the way the brain responds to stimuli in the airway. This multi-site randomized clinical trial will evaluate the mechanisms underlying response to BCS therapy, allowing us to more efficiently and effectively treat patients with RCC in the future.